Administrative Core for Gene Therapy of Hemophilia

The Administrative Core is organized to provide support and oversight for the Program Projects. It is designed to facilitate exchange of ideas and scientific interactions among Projects and Cores. Core A will continue to serve as the communication center where our internal and external committees can channel their comments to individual project/core leaders, as well a central place that the Internal and External Advisory Boards can monitor project progression. Core A will keep our internal advisory board (Drs. Bennett, Haskins, June and Wright) and our external advisory board (Drs. Bray, Hedner and Schaub) updated about experimental outcomes on a semi-annual basis. It will provide services to individual projects in areas such as budget control, abstract and manuscript preparation, and meeting scheduling.